Mechanisms linking CFTR to dysregulated barrier function, insulin receptor function, and glucose transport in the CF lung

PROJECT SUMMARY
In Cystic Fibrosis (CF), one of the most common lethal genetic diseases in the U.S., loss of CFTR function
leads to the well-known triad of infection, inflammation, and obstruction, resulting in progressive loss of lung
function. As CF patients develop CF-related diabetes (CFRD), the most common CF comorbidity, lung function
decline is accelerated. Despite the high frequency and substantial clinical significance of CFRD, little is known
about how the development of systemic hyperglycemia worsens airway function in CF.
Published work from the McCarty-Koval labs detailed the discovery of fundamental defects in the handling
of glucose in the CF airway, including impacts on both the function of tight junction proteins in limiting flux of
glucose into the airway and the function of transporters to remove airway glucose from the airway surface
liquid (ASL), two arms that together generate an “airway glucose barrier.” Furthermore, our results show that
non-CF airway epithelial cells responded to insulin by enhancing barrier function, while cells expressing mutant
CFTR (CF cells) responded to insulin by weakening barrier function. New preliminary data suggest that while
insulin-mediated signaling in non-CF cells occurs through the “metabolic” pathway, supportive of tight junction
integrity and glucose uptake, insulin-mediated signaling in CF cells occurs through the “mitogenic” pathway,
which is detrimental to barrier integrity. Our general hypothesis is that expression of mutant CFTR alters
expression and localization of tight junction proteins to impact barrier function while also altering glucose
transport from the ASL, and that insulin signaling pathways serve as a hub to coordinate the activities of both
barrier and glucose transport functions; we also hypothesize that acute ingestion of glucose in CF patients
leads to increased glucose abundance and enhanced oxidative stress in the airway. The goal of this proposal
is to determine the underlying mechanisms for dysregulation of glucose barrier function in the CFRD airway.
Aim 1 will identify mechanisms that link expression of mutant CFTR to altered insulin receptor function and
impacts of hyperglycemia and airway redox stress. Aim 2 will identify mechanisms linking expression of mutant
CFTR to altered glucose barrier function and impacts of hyperglycemia and redox stress. Aim 3 will determine
the kinetics of change in glucose abundance and glucose-induced redox imbalance in the CFRD airway in
response to oral glucose challenge in human subjects in a small clinical study.
This highly mechanistic proposal builds upon strong preliminary data and takes advantage of an
outstanding investigative team comprised of experts in cell biology, gene expression, diabetes, and redox. The
potential impacts of this research include the identification of mechanism(s) linking diabetes to enhanced
pulmonary decline in CFRD and identification of pathways that could be therapeutically targeted to control
airway glucose and its effect on pulmonary disease progression.

Public health relevance
NARRATIVE - RELEVANCE TO DISEASE Cystic Fibrosis (CF) is one of the most common lethal genetic diseases in the United States and is characterized by progressive lung destruction; as patients age, they most often experience systemic hyperglycemia that leads to accelerated decline in pulmonary function in the common co-morbidity known as CF-related diabetes (CFRD). The goal of this new, vertically integrated proposal is to determine the mechanisms underlying defects in barrier function and insulin-mediated signaling which lead to elevated airway glucose, hastening the CF patient toward death. The overall impact of this research plan includes identifying mechanisms linking the impairment of CFTR function to pulmonary effects of CFRD and identification of pathways with the potential to be therapeutically targeted to control airway glucose to mitigate the effects of CFRD on the progression of CF associated pulmonary disease.